Impact of inverse relationship between TP53 and CARF on the development of hepatic steatosis and insulin resistance

Project Summary:
With the dramatic increase in obesity and diabetes, the prevalence of nonalcoholic fatty liver diseases
(NAFLD) is increasing at an alarming rate worldwide. NAFLD is a significant risk factor for insulin
resistance (IR), type 2 diabetes (T2DM), and cardiovascular diseases. We need to understand the underlying
molecular mechanisms adequately to manage NAFLD and T2DM clinically. CARF is a novel p53 pathway
protein that interacts with p53 and regulate its functions. Previous studies reported that an inverse
relationship exists between CARF and p53. We posit that p53-CARF interplay plays a vital role in the
outcome of p53 actions responding to various stressors. Our recent publication showed that free fatty acid
(FFA)-induced stress suppressed hepatic CARF that triggered fat deposition in the liver, while exogenous
delivery of CARF prevented it. Further, we found that silencing of CARF perturbed insulin signaling
pathway in hepatocytes. Most intriguingly, expression of PCK1, a key hepatic gluconeogenic gene, was
increased after silencing of CARF in hepatocytes. This led us to propose that CARF is a transcriptional
regulator of PCK1 and, hence hepatic glucose output and IR. Growing evidence suggests that metabolic
stress-induced p53 could alter the cell's metabolic homeostasis leading to the development of NAFLD and
IR in both humans and rodents. Notably, our preliminary data further showed that CARF expression was
decreased in HFD-fed livers with increased p53, thus establishing an inverse relationship. However, the
role of this inverse relationship in metabolic stress and its outcome are unknown. We hypothesize that
CARF could be a downstream target of p53 in metabolic stress. Its inhibition drives the development of IR
and NAFLD. Using in vitro cellular and in vivo mouse models of NAFLD and IR integrated with the ChIP-
sequencing, CUT and RUN sequencing, Co-IP, ITT, GTT, and PTT assays, this study will uncover a novel
function of CARF -p53 interplay in the development of NAFLD and IR. Understanding this mechanism
could reduce a considerable health burden in the USA and worldwide. This SuRE grant will create an
opportunity for mentoring underserved undergraduate and graduate students to complete their research
thesis at Charles R. Drew University of Medicine and Science. Recent data show that the student population
at Charles R. Drew University of Medicine and Science is 35% Black and 25% Hispanic. By integrating
student training with the proposed research plan, this grant will help students to acquire considerable
technical skills and the expertise necessary to perform high-quality, basic, and translational biomedical
research.

Public health relevance
Project Narrative: The increasing prevalence of insulin resistance (IR) and non-alcoholic fatty liver diseases (NAFLD) in the USA requires continued effort to define underlying mechanisms and identify new drug targets. This project will investigate the causative role of P53-CARF interplay in IR and NAFLD and establish that understanding its function will help manage IR and NAFLD.